Transfer of function across equivalence classes: Implications for substance use

PROJECT SUMMARY
The importance of complex learning, memory and verbal/symbolic processes in the
development, maintenance and relapse of substance use disorders (SUDS) is increasingly
being recognized. Drug-related cues and behaviors develop and alter in value based on direct
association with drug experiences but are also determined by verbal and other symbolic
processes. Research on these aspects of SUDS is hampered by the limited availability of
animal models of such processes. The two PIs, Dr. Galizio and Dr. Bruce, have developed a
model of symbolic processes in rats: classes of olfactory stimuli that are physically dissimilar but
are related through a history of association. Twelve odors are arbitrarily partitioned into two sets
of six. Rats are trained to make instrumental responses for reward to one set with no reward for
the other until they are responding exclusively to the rewarded set. Then reward contingencies
are repeatedly reversed and, after extensive training with these procedures, the animals begin
to show transfer of responding or non-responding to all members of each set after exposure to
just a few. This transfer of function among stimuli without direct exposure to the changed
contingencies defines a functional equivalence class and the proposed research will explore
whether these classes share key properties with human symbolic classes or categories. Aim 1
will test whether pairing of a novel stimulus with one class member will result in the novel
stimulus coming to be related to all class members without explicit training. This is called class
expansion and is readily demonstrated in humans. Aim 2 will test whether transfer of a novel
instrumental response across class members will occur in rats as they do in humans. Aim 3 will
test transfer of a Pavlovian conditioned response across class members assessed in a cue-
induced reinstatement paradigm. Finally, in a proof of concept experiment, Aim 4 will examine
whether an odor preference induced by pairing with morphine will transfer to other class
members. These studies form the basis for a model of symbolic processes in rats with potential
translational value to the treatment of SUDs.

Public health relevance
PROJECT NARRATIVE Development of an animal model of symbolic processes has broad relevance for public health. A successful model will permit translational research on the role of learned symbolic associations in the acquisition, maintenance and relapse of substance use and other mental health disorders. Thus, the research is relevant to NIH’s mission that emphasizes gaining knowledge to enhance health and prevent illness.